Ultrafast Dynamic contract optical coherence tomography for high-throughput anti-cancer drug screening

Improving the success rate of oncology drug development requires pre ... clinical models that better mimic in
vivo tumor environments and advanced imaging tools capable of real-time monitoring of treatment
responses. Tumor organoids represent a biologically relevant 3D cancer model, yet existing imaging
platforms fall short in achieving both high temporal resolution and high throughput. To address this critical
gap, we propose to develop an ultrafast Dynamic Contrast Optical Coherence Tomography (DyC-OCT)
system empowered by artificial intelligence (Al) for label-free, high-throughput 4D imaging of tumor
organoids.